IFN-I production in vivo for resistance to acute disseminating viral Infections

Summary Type I Interferon (IFN-I) is the name of a family of anti-viral cytokines. In humans and mice, the predominant IFN-I subtypes are a single IFN-β and multiple IFN-αs (14 in mice and 13 in humans) which are encoded by a set of short intron-less genes clustered in a ~300 kb locus (chromosome 9 in humans, 4 in mice). IFN-β has ~25- 30% of homology with the different IFN-αs and the IFN-αs of a given species have ~85% homology among them. Notably, the multiplicity of the IFN-αs emerged independently through gene duplication and conversion in most eutherian mammals suggesting a strong evolutionary pressure to increase the number of IFN-α genes. In this project we will use novel mouse models produced in the lab and three different viruses -ectromelia virus (ECTV), West Nile Virus (WNV) and Zika Virus (ZIKV)- to fill three major gaps in our understanding of the IFN-I field. The first knowledge gap is that we do not know what is the role of the so called “early” IFN-β and IFN-α4 in resistance to viruses that disseminate lymphohematogenously. When fibroblasts are infected with RNA viruses in vitro, IFN- β and IFN-α4 are produced immediately after infection and are required for the expression of IFN-α non4 (all the IFN-α except IFN-α4). The reason for this is that to be transcribed, the promoters of IFN-β and IFN-α4 can use the transcription factors IRF7, IRF3 and/or NFκB while IFN-α non4 can only use IRF7. While IRF3 and NFκB are constitutively expressed in most cells, IRF7 is an interferon inducible gene (ISG). Thus, the transcription of IFN- α non4 depends on a positive feedback loop or “priming” by IFN-β and/or IFN-α4. Yet, whether IFN-β and IFN- α4 regulate IFN-I transcription in vivo and are required alone or together for resistance to viral diseases is unknown. Thus, in Aim 1 we will use novel mouse models infected with ECTV, WNV or ZIKV to determine the roles of IFN-β and IFN-α4 in the regulation of the IFN-I response and resistance to acute viral diseases in vivo. The second knowledge gap is that we do not know why there is a need for so many IFN-Is. It is possible that they have additive and/or differential biological effects. Thus, in Aim 2 we will investigate the need for multiple IFN-Is in resistance to viral diseases using novel mouse models infected with each of these three viruses and supplement Ifna-/- mice with different IFN-αs. The third knowledge gap is that we do not know whether there are specific cell types that must obligatory produce IFN-? for resistance to viral infections. Preliminary results with ECTV suggest that cells of hematopoietic origin are obligatory IFN-I producers, at least for ECTV infection. Therefore, in Aim 3 we will use bone marrow chimeras and mice with conditional deletions in IFN-? in different cell types to identify cells that are necessary producers of IFN-I for each of the different viruses. Thus, using novel mice, we will fill three knowledge gaps in our understanding of how IFN-I protects from viral diseases. By using multiple viruses, we will be able to draw general conclusions and to identify virus-specific differences. Our work should inform development of new therapeutics for improving resistance to acute viral diseases.

Public health relevance
Statement In the proposed work we will fill three knowledge gaps in our understanding of how IFN-I protects from viral diseases. By using multiple viruses, we will be able to draw general conclusions and to identify virus-specific differences. Our work has potential to inform development of new therapeutics for improving resistance to acute viral diseases.